Neural Circuitry of Motioninduced Nausea

PROJECT SUMMARY
Nausea is a queasy sensation that arises from interoception of physiological distress within the body. However,
there remains a critical gap in the fundamental understanding of neurons and neural circuits responsible for this
debilitating condition. This proposal focuses on motion sickness (originating in the brain) rather than chemically
induced nausea (originating in the viscera), thereby providing an innovative, orthogonal view into the cellular and
circuit mechanisms of nausea. The overall objective in this application is to understand how motion-induced
nausea is elicited in the brain. The central hypothesis posits that specific neurons in the caudal hindbrain are
responsible for the sickness. This hypothesis will be tested in mice by addressing the following three specific
aims: 1) Establishing the necessity and sufficiency of discrete subsets of hindbrain neurons for motion-induced
nausea; 2) Identifying the genetic profile defining hindbrain neurons associated with nausea; and 3) Mapping the
presynaptic to and postsynaptic connections from these neurons. The proposed research is significant because
it will reveal the molecules, cells, and circuits responsible for motion-induced nausea. The anticipated outcomes
of these studies promise unique and powerful inroads into how the mammalian brain processes distress signals
from the body and orchestrates responsive measures.

Public health relevance
PROJECT NARRATIVE Motion sickness is a debilitating condition with profound effects on well-being. In contemporary society, more than a third of the population encounters dizziness or nauseousness through various modes of transportation, virtual reality, or cyber sickness. The proposed research aims to delve into the pathophysiology of motion- induced nausea, shedding light on its underlying mechanisms and presenting potential avenues for therapeutic intervention.